NIH Support for the Human Fronteir Science Program

This agreement provides support for the Human Frontier Science Program (HFSP) which is a multinational program supporting grants and fellowships in the neurosciences and cellular biology.